Methods and Logic in Molecular Biology Training Program

The Methods and Logic in Molecular Biology training program (MLMB) at Princeton University educates carefully
selected individuals for the research, teaching, and advocacy needs of the nation. The MLMB brings together
the multi-disciplinary life science community at Princeton with 54 training faculty. Our program is highly
collaborative and trains students to acquire the skills to become leaders in any field they choose. The MLMB
training faculty represent 7 academic departments and 3 research institutes, including 33 from Molecular Biology,
4 from Chemistry, 5 from Chemical & Biological Engineering, 2 from Ecology & Evolutionary Biology, 3 from
Computer Science, 2 from Physics, 2 from Mechanical & Aerospace Engineering, 1 from the Lewis Sigler
Genomics Institute, and 2 from the Neuroscience Institute. The faculty provides expertise in diverse biological
model systems, offering training in genetics, genomics, proteomics, metabolomics, biochemistry, biophysics,
cancer, cell biology, development, microbiology, immunology, and neuroscience. All faculty are themselves
rigorously mentored, undergoing annual mandatory mentoring training, and assessed by the MLMB Committee.
The MLMB is administratively supported by the Department of Molecular Biology (MOL) and selects its students
from the pool of MOL graduate students. The MLMB is the only training grant that supports MOL students. The
MOL graduate program receives over 400 applications per year, attracting some of the best students in the
country. Research is performed in well-equipped laboratories with support from state-of-the-art core facilities.
The training program consists of inter-disciplinary, skill-building oriented course work, laboratory rotations, a
general exam, thesis research, thesis committee meetings, Individual Developmental Plans, and an array of
MLMB specialized courses and activities that provide students with science communication, leadership, and
managements skills, in conjunction with diverse career development opportunities. Trainees gain teaching
experience and receive intensive training in scientific rigor/reproducibility and responsible conduct of research.
Our Mentorship Program further helps all students with issues such as work/life balance and career
development. We have a successful Diversity and Inclusion Program to help recruit and retain students from
groups that are under-represented in the life sciences. Our gender and racial demographics have matched those
of the nation for over a decade. Routine internal and external assessment of the MLMB Training Program
evaluates both faculty and students and enables us to identify needs for new courses, policies, and activities
that keep the program fresh. Our success is best judged by the productivity and success of our graduates.
Students who graduated in the past 10 years had an average of 4.1 publications per trainee and 95% are still
engaged in science-related careers. Our MLMB program thus nucleates the vibrant multi-disciplinary research
community at Princeton and delivers scientists broadly trained with the interdisciplinary skills they need to solve
tomorrow’s challenges. Support for 12 trainees for their 2nd and 3rd years (24 slots) is requested.

Public health relevance
The Methods and Logic in Molecular Biology (MLMB) Training Program at Princeton University is a diverse and inclusive program that trains graduate students to become leaders in biomedical research, teaching, and related life science fields. We use a customized mentoring program that provides MLMB trainees with advanced skills in multi-disciplinary research, including critical thinking, generation of hypotheses, experimental design, data analysis and interpretation, and science communication, in conjunction with skills in leadership and mentoring. Research projects directed by MLMB program faculty train Ph.D. candidates in diverse areas related to human health, including reproduction and development, infectious disease, cancer, and aging.